Sequence transformations and microbiology: theory, tools, & discovery

Project Summary
String similarity is one of the foundational problems in computational biology – it is what allows
piecing together a genome from short sequenced read substrings, determining that human
genomes share a more recent common ancestor with chimpanzee than they do with octopus,
and detecting the horizontal transfer of genetic material across bacterial species, one of our
current application focuses. Exact sequence matches between genomes is a long-solved
problem, but in biology, due to the prevalence of both mutation and sequencing error, we care
more about approximate matches, which are much harder to find and characterize. One of the
major recent advances in bioinformatics has been the advent of increasingly sophisticated string
transformations (sketching, k-mer-ization, alphabet reductions) that change the distribution of
exact matches on the transformed strings, allowing for the development of faster software.
My nascent research lab has been one of the pioneers in both developing rigorous
mathematical theory to understand sequence transformations and in engineering software that
turns that theory into usable bioinformatics software. Relevantly, in prior work, we gave the first
rigorous proofs that k-mer sketching works with alignment [Shaw & Yu, Genome Research,
2023] successfully translated our theoretical understanding of k-mer sketching theory into a new
metagenomics software “skani” [Shaw & Yu, Nature Methods, 2023] for computing pairwise
average nucleotide identity (ANI), a standard measure of genome similarity. Skani is both more
accurate and orders of magnitude (20x) faster than the state-of-the-art. Building on skani, we
further produced skandiver [Zhang et al., Bioinformatics, 2024], a tool for detecting large
intercellular mobile genetic elements by comparing all the chunks of a sequence against all the
whole genomes in a database, without needing a reference database of mobile genetic
elements specifically.
Over the next five years, my research program will continue to straddle the line between
advancing string algorithm theory and using that to build bioinformatics tools. On the theory
side, we want to combine ideas from k-mer sketching theory with alphabet reductions to expand
the utility of sketching for more dissimilar sequences (such as found in protein databases). On
the applied side, we are going to push forward string similarity tools for microbial analysis,
focusing on better characterizing mobile genetic elements – our proof-of-concept skandiver only
does long-all-to-all-sequence similarity, and its design principles don’t work for intra-species
MGEs, small MGEs, or even annotate the boundaries of the MGEs it does find.

Public health relevance
Project narrative Databases of microbial genomes have been expanding rapidly, but our software tools have not kept up, especially when it comes to identifying mobile genetic elements. This is in part due to open questions in the theory of string transformations for fast similarity search, and in part due to lack of good reference databases for sequences that move between species. In this project, we develop new mathematical theory in k-mer sketching and alphabet reduction to design software that is both faster and more accurate for analyzing microbial genomes for mobile elements.